The Role of Local Sleep Disturbance in Obesity Risk: A Sleep Neuroimaging Study

PROJECT SUMMARY/ABSTRACT
With obesity prevalence at never-before-seen incidences, there is an imperative need to identify modifiable
behavioral and physiologic targets to reduce obesogenic risk factors. Poor sleep is a modifiable therapeutic
target that recent neuroimaging research indicates plays a vital role in obesity. However, the mechanisms that
drive the relationship between poor sleep and obesity are elusive and unclear. New and advanced neuroimaging
and sleep methods hold promise in helping to determine when and how poor sleep imparts risk for physical
health disorders generally and obesity specifically. Sleep neuroimaging uses advanced functional neuroimaging
techniques concurrent with polysomnographic methods to obtain a clearer and more detailed picture of brain
activation patterns that occurs during sleep; such novel information can help elucidate previously undiscovered
mechanisms linking sleep with obesity so that the underlying mechanisms can be more directly targeted in
prevention and treatment efforts. There is increasing realization that sleep, and its restorative functions, are
regionalized processes localized in the brain and can become disrupted regionally. In our model, we propose
that regionalized sleep disturbance prevents restorative benefit to those regions, thereby resulting in daytime
impairments specific to those brain regions affected during sleep, a process called local sleep disturbance. This
comprehensive sleep neuroimaging study includes gold-standard measures at various levels of analysis (e.g.,
dim-light melatonin onset assessment, polysomnography, actigraphy, and self-reported sleep questionnaires
and diaries) in conjunction with functional magnetic resonance neuroimaging during non-rapid eye movement
sleep to understand (Aim 1) how functional connectivity during sleep relates to obesity-related outcomes (i.e.,
dietary behaviors, sedentary behavior, neural activation in brain regions associated with food-related reward and
inhibition), (Aim 2) how differences in network-level functional connectivity during sleep, as a marker of local
sleep disturbance, may mediate the association between poor sleep and obesity-related outcomes, and (Aim 3)
explore how the relationship between functional connectivity during sleep and obesogenic risk factors differ
across individual factors including developmental status (adolescents and young adults) and sex. This research
will use innovative methodologies to uncover critical mechanisms that link poor sleep with obesity, which has the
potential to inform preclinical models sleep health and general wellbeing. Furthermore, this research will provide
support for meritorious research at an undergraduate-focused institution (Brigham Young University) by
providing undergraduate students with advanced, active biomedical research experience, all of which will
ultimately strengthen the research environment present at Brigham Young University and feed the sleep
medicine pipeline with well trained and experienced individuals.

Public health relevance
Our sleep neuroimaging research is relevant to public health because it uses cutting-edge neuroimaging methods with established sleep research methods to identify the mechanisms underlying the sleep-obesity association, which will inform preclinical models that promote overall health. Our study, assisted by undergraduate students, will investigate local sleep processes as a potential mechanism through which poor sleep confers risk for obesity. This research fulfills the NIH Sleep Research Plan to uncover the sleep and circadian mechanisms underlying health and disease.